PERCEPTION OF AIRWAYS OBSTRUCTION IN ASTHMA

The difficulties experienced by patients and physicians in recognizing asthma severity may explain the increase in morbidity and mortality from this illness. The project monitors adults with asthma over a three week period to correlate fluctuations in symptoms, medication use, peak expiratory flow rates, with mood and psychological stressors. A hand-held computer, electronic peak flow meter, and electronic device for reporting albuterol use are employed. Twenty-two patients have completed the study to date. Approval at a second site, St. Francis Hospital to enroll patients will significantly increase the number of minority patients to be enrolled.